Mentoring and Research in Patient-Oriented Integrative Medicine

MENTORING AND RESEARCH IN PATIENT-ORIENTED INTEGRATIVE MEDICINE
The renewal Midcareer K24 Award is for Dr. Chenchen Wang to continue her mentoring of the next generation
of physician-scientists and to contribute to patient-oriented Integrative Medicine research. Dr. Wang is
Professor at Tufts University School of Medicine and Director of the Center for Complementary and Integrative
Medicine and holds a strong record of research, publication, and mentoring. Her long-term goal is to advance
the science of Integrative Medicine to promote health and healing. Her immediate goals are to obtain protected
time to expand and strengthen her innovative, multi-method, and multidisciplinary translational research and
mentoring programs for chronic disabling conditions.
In the First Four Years of the K24, the PI has completed four major NIH-funded clinical trials studying
comparative effectiveness of mind-body interventions for chronic musculoskeletal pain, developing integrative
treatment approaches in military and veterans populations, and provided groundbreaking evidence on
neurobiological and physiological responses to mind-body interventions. In this period, the PI published 61
articles, 8 as first author and 53 as senior author. The PI and her mentored team also received a new R01-like
grant from the U.S. Department of Veterans Affairs to investigate the efficacy of a mind-body intervention for
veterans suffering with Gulf War Illness. During the initial K24 period, she has been primary or co-primary
mentor for 23 trainees with doctoral degrees. Her trainees authored 41 first-authored peer-reviewed
publications and had 64 co-authorships. Ten of her trainees have their own NIH or other career grants. Dr.
Wang’s multidisciplinary mentoring program, as well as her expertise on mind-body interventions, has been
fully integrated into the research and teaching infrastructure of the Tufts Clinical and Translational Science
Institute. With access to these outstanding resources and a long-recognized diverse training environment, her
selected mentees will continue to obtain training in the rigorous scientific methodology, integrity, ethics, and
grant applications necessary to stimulate high-quality, translational, patient-oriented research.
The goal of this proposed K24 renewal is to build upon previous and current findings of the PI’s NIH-funded
studies to: 1) expand and evaluate translational Integrative Medicine research for chronic disabling conditions
in order to inform and benefit medical practice; 2) advance fundamental neuroscience and human biology
research to understand the mechanisms of mind-body approaches, with the goal to improve chronic pain
management; 3) identify critical unmet needs of novel effective therapies for managing symptoms; and
4) further strengthen the comprehensive interdisciplinary mentoring plan and extend opportunities to new
scientists to guide future generations of Integrative Medicine researchers. This K24 renewal will therefore
promote multidisciplinary patient-oriented research for the next generation of investigators in order to
substantially advance the science on complementary and integrative medicine and contribute to the health,
healthcare, and well-being for all.

Public health relevance
PUBLIC HEALTH RELEVANCE (PROJECT NARRATIVE) The complementary and integrative medicine approach offers promising therapies to affect the progression of disease while simultaneously diminishing pain and morbidity. This K24 Midcareer Investigator Award renewal will expand and strengthen Dr. Wang’s multidisciplinary mentoring and research program for the next generation of integrative medicine researchers. The program will substantially advance the science of Integrative Medicine to contribute to the direction of future medicine.